Whole Health in VA Mental Health: A Randomized Controlled Trial of Omnis Salutis

Anticipated Impacts on Veteran Healthcare: Recent Veterans of the Operation Enduring Freedom, Operation
Iraqi Freedom and Operation New Dawn (OIF/OEF/OND) conflicts are presenting in VA care with high rates of
stress related mental health disorders (posttraumatic stress disorder, depression, anxiety, and alcohol abuse),
and reporting significant difficulties with social relationships and community reintegration. Surveys of recent
Veterans show that Veterans want the VA to provide mental health care tailored to their concerns and
reintegration priorities; while simultaneously, the VA has committed to transforming to a Whole Health patient-
centered, system of care. Within this context, Omnis Salutis, a brief, Veteran-focused, Whole Health activation
intervention, was developed with a stakeholder advisory panel of Veterans, clinicians, and researchers.
Preliminary findings indicate that participation in Omnis Salutis was associated with improvements in physical,
mental and social functioning among recent Veterans with stress related mental health disorders.
Project Background: The term “recent Veterans” refers to Veterans who served in the OIF/OEF/OND military
operations. Almost 60% (708,062) of recent Veterans who received VA care have been diagnosed with a
mental health disorder, most commonly post-traumatic stress disorder (56%), depressive disorders (45%),
anxiety disorders (44%), and substance use disorders (21%). Recent Veterans with stress-related mental
health disorders experience impairment in functional domains of health (overcoming and managing disease),
purpose (meaningful daily activities and participation in society), and community (positive relationships and
social networks). Omnis Salutis is a three-session intervention in which Veterans learn about Whole Health
and complete a brief Personal Health Inventory, practice creating and delivering MY MAP
(Mission/Aspiration/Purpose) to communicate their health mission consistently to their providers and social
supports; and identify both formal and informal healing relationships that support their health mission. Omnis
Salutis was shown to be acceptable to and feasible in a previous small randomized controlled trial (n = 48).
Additionally, analyses of the relationship between participation in Omnis Salutis and outcomes on the Veterans
RAND 36-Item Health Survey found a large effect for Bodily Pain improvement, medium effect size for Social
Functioning, small effect sizes for Physical Functioning, Emotional Well-Being, Energy/Fatigue, Role
Limitations due to Emotional Problems, and General Health. These results are very promising and support
further testing of Omnis Salutis.
Project Objectives: The proposed research will test the efficacy of Omnis Salutis, a brief, Veteran-focused,
Whole Health activation intervention, in a randomized controlled trial (n = 238). The primary aim of the study is
to evaluate the efficacy of Omnis Salutis for improving the physical and social functioning of recent Veterans
with stress-related disorders. The secondary aim is to evaluate the efficacy of Omnis Salutis for increasing
Veteran engagement in care for stress-related disorders. There is an exploratory aim to Evaluate the
processes that underlie the relationship between engagement in care and functioning. This study will provide
support for Omnis Salutis as an evidence-based practice and for broader dissemination.
Project Methods: We propose a randomized controlled trial in a sample of 238 Veterans with stress-related
mental health disorders recruited from four VA medical centers in Maryland, Washington DC, and West
Virginia. Veterans will be randomly assigned to receive three sessions of Omnis Salutis or three sessions of an
active control, health, and wellness intervention. Both conditions will be delivered via as VA Video Connect
(VVC) telehealth platform or telephone. Participants will complete assessments at baseline, 3-month follow-up,
6-month follow-up, and 12-month follow-up timepoints. Analyses will examine differences in change over time
between the two intervention conditions.

Public health relevance
Recent Veterans of the Afghanistan and Iraq conflicts are presenting in VA care with high rates of post- traumatic stress disorder (PTSD), depression, anxiety, and substance use disorders. Difficulties with social relationships and community reintegration are common functional impairments with these disorders. VA is transforming to a Whole Health, patient-centered system of care that will address these issues as part of health care. In a previous study, Omnis Salutis (OS) was developed with Veteran and clinician input. OS is a three- session intervention in which Veterans learn about Whole Health and practice communicating their health mission to providers and social supports. OS was shown feasible to deliver, acceptable to Veterans, and preliminarily effective at improving physical, mental, and social functioning. This study will use a large, multi- site randomized controlled trial to test the impact of OS on Veterans’ social and physical functioning and Veteran engagement in mental health care. Results will support broad delivery of OS throughout the VA.